Biobehavioral Oncology Training Program

ABSTRACT
This new T32 resubmission application supports a postdoctoral research training program in biobehavioral
oncology at the Medical College of Wisconsin (MCW) in Milwaukee. The two-year Biobehavioral Oncology
Training (BBOT) Program will support two new fellows per year for a steady state of four and total of 10 over the
funding period. Our program integrates the cross cutting theme of cancer disparities from prevention to
survivorship. Our preceptors are members of MCW's Cancer Center, which is on a strong trajectory toward NCI
designation. The BBOT Program is an interdisciplinary program that considers the contribution of biological and
behavioral factors to cancer prevention, control and treatment response through the integration of two themes:
1) the biology of stress and disparities, and 2) social determinants of health, behavior, and outcomes. It is the
first training program in Wisconsin to address the biological and behavioral aspects of cancer prevention and
control and the first cancer-focused training program at MCW. The primary objective of this proposal is to produce
successful independent cancer research leaders who come from diverse population groups to remediate cancer
health disparities by incorporating biological and behavioral aspects into their cancer research. BBOT will be
supported by 20 primary mentors, all funded PIs with grants totaling $18M in annual cancer-relevant extramural
support. Mentors include 13 PhDs, six MDs, and one MD/PhD appointed in 12 departments and
interdepartmental programs. Additionally, six junior mentors with relevant expertise will participate in a Junior
Mentoring Program, serving as associate mentors to BBOT trainees. Collectively, mentors have outstanding
expertise in epidemiology, basic cancer biology, genetics, biostatistics, neuroscience, immunology, and
behavioral medicine and interventions, offering research opportunities focusing on the interactions of genetic,
molecular, neural, psychological, behavioral and social factors and their impact on cancer. Informed by an
individualized development plan, the training program includes four components designed to prepare trainees to
launch and sustain successful research careers: i) didactic learning; ii) multidisciplinary biobehavioral oncology
mentored research experience; iii) career development; and iv) community engagement. Milwaukee is the fifth
poorest and one of the most segregated cities in the US and is home to the majority of Wisconsin's African
American, Hispanic and Hmong communities. The BBOT experience and training goals are designed to develop
a diverse cadre of scientists who will dedicate their careers to ameliorating the persistent cancer disparities
manifest in our city and across the nation. Internal and External Advisory Committees will provide ongoing
evaluation and feedback to ensure that program goals are effectively met. BBOT has enthusiastic and robust
institutional support from the Program Directors' department chairs, the MCW Cancer Center director, and the
dean of the MCW School of Medicine, all of whom have allocated substantial resources to ensure its success.

Public health relevance
PROJECT NARRATIVE This proposal describes a new NCI-supported postdoctoral Biobehavioral Oncology Training (BBOT) Program with a cross cutting theme of cancer disparities. This transdisciplinary training program in the biobehavioral aspects of cancer prevention, control and treatment response addresses 1) the biology of stress and disparities and 2) social determinants of health, behavior, and outcomes. Through outstanding mentorship, research, and training experiences, the goal of the BBOT Program is to prepare the next generation of biobehavioral oncology researchers for successful research careers devoted to ameliorating disparities in cancer health outcomes.